Administrative Core

ABSTRACT
Administrative Core (Peter J. Gianaros, CL)
The Administrative Core will be responsible for the overall administrative and intellectual coordination of the
Program Project, from participant accrual to dissemination of findings. It will provide centralized fiscal
management of the Program and ensure adherence to NIH and institutional grants management policies and
IRB compliance. The Core will implement recruitment procedures for subject enrollment; oversee development
of the Manual of Operations governing procedures of data collection; and issue payments to study participants.
In its oversight role, the Core will monitor data collection, entry and verification through reporting protocols
for subject tracking, protocol adherence, and problem identification. Finally, the Core will organize and
coordinate regularly scheduled scientific interactions among collaborating investigators, consultants, and
laboratories; foster training of junior scientist collaborators; and, aid in disseminating findings for use by the
broader scientific community through the program's Data Sharing Plan. In his role as Program Director and
Core Leader, Dr. Gianaros will be supported by an Operations Director for coordination of key day-to-day
activities (Dr. Manuck) and advised by an Executive Committee, Internal Scientific Advisory Committee, and
an External Advisory Board composed of senior scientists from other institutions.

Public health relevance
PROJECT NARRATIVE Administrative Core The Administrative Core will provide logistical support to the 3 Projects and other Core Units of this research program, including centralized administrative and fiscal management; participant recruitment, enrollment and scheduling; development of the Manual of Operations governing program procedures; oversight of data acquisition and management via monitoring protocols; oversight of participant confidentiality; and issuance of study payments. The Core will also provide intellectual leadership by coordinating scientific interactions among collaborating investigators, consultants, board members, and laboratories, culminating in timely publication of Program findings and distribution of study data and tools in the public domain.